Peripheral optical and neural contributions to myopia development

Abstract
Myopia (nearsightedness) is one of the foremost causes of visual impairment worldwide, with severe myopia
being linked to several serious eye diseases that can result in permanent blindness. The prevalence of myopia
has been increasing and is estimated to affect 50% of the world’s population by 2050. Despite the identification
of many risk factors for myopia progression such as age of onset, genetics, visual environment, and peripheral
defocus, causes of myopia are not fully understood. Current interventions have shown some success, but
without a clear explanation for their mechanism of action. It is therefore critical to investigate the mechanisms
underlying myopia development in order to design effective interventions to control the progression of myopia
in children, and to delay or ultimately prevent onset altogether. Our long-term goal is to understand the
influence of peripheral optical and neural factors on myopia development. The specific objective of this
proposal is to test the central hypothesis that optical and neural anisotropy in the human peripheral visual
system plays an important role in axial elongation. To achieve these goals we will develop and implement
innovative optical tools including a compact scanning ocular wavefront sensor, an open-view scanning
adaptive optics vision simulator, and individually-customized contact lenses. Aim 1 is directed at characterizing
how different aberration profiles impact through-focus retinal image quality and neural functions. First,
measuring lower and higher order ocular aberrations across retinal eccentricity will characterize individual
retinal image quality and blur orientations. Neural anisotropy at the same eccentricities will then be evaluated
by administering psychophysical tasks while bypassing the ocular optics using a scanning adaptive optics
vision simulator. Aim 2 will focus on determining how intrinsic peripheral aberration profiles and eye shape
change over time in school children. To do this, we will develop a compact portable scanning wavefront sensor
that can be transported to and used in a clinic for measuring longitudinal changes of school children’s optics
across retinal eccentricity. This will allow us to delineate relationships between changes in peripheral
aberrations at the crucial stages of myopia development, in those children who develop myopia. Aim 3 is
proposed to further investigate a role of blur orientations in detecting the sign of defocus and altering
directional neural sensitivity in the peripheral retina. To achieve this goal, the retinal response in term of
changes in choroidal layer thickness (short-term) and neural sensitivity (long-term) will be examined during and
after the peripheral retina is exposed to specific blur orientations.

Public health relevance
Narrative Myopia, also known as nearsightedness, is a common visual impairment that can lead to serious diseases that cause permanent vision loss in some cases. The proposed project uses novel optical and psychophysical approaches to evaluate the optical and neural characteristics in the human peripheral visual system, revealing mechanisms underlying myopia development.